FOLLICULAR ASPIRATION AT LAPAROSCOPY

The goal of this study is to attempt to clarify the reason older women are more likely to have chromosomally abnormal babies. Follicular fluid is obtained from women undergoing laparoscopy. The analyses for androsteindione and estradiol levels are done in the GCRC Core Laboratory.